Endogenous circadian mechanisms underlying cardiovascular risk

PROJECT SUMMARY/ABSTRACT
Endogenous circadian clocks exist in all cells and tissues, including the autonomic nervous system, heart, and
vasculature. The resultant rhythms prepare the cardiovascular (CV) system for optimal function to match the
daily anticipated behavioral and environmental cycles, such as altered posture and increased activity after
awakening in the morning. However, the morning is also the most vulnerable time for adverse CV events,
including myocardial infarction, stroke and sudden cardiac death. Dr. Shea has pioneered the use of intensive,
multi-day laboratory experiments and uncovered substantial endogenous circadian rhythms across the CV
system in healthy humans. Dr. Shea also discovered that circadian rhythms exist in the CV reactivity to stressors
(i.e., there are different CV responses to identical stressors at different times of day). Dr. Shea’s work has led to
the concept that circadian rhythms in the CV system act as a ‘double-edged sword’: the normal amplified
responses in the morning aid the transition from sleep to activity in healthy individuals, but such exaggerated
responses are potentially perilous in individuals with underlying CV risk factors who are susceptible to adverse
events. Dr. Shea will lead a multi-disciplinary team of outstanding investigators to examine the broad question
of how the circadian system interacts with behavior-related CV responses to produce predictable daily variations
in CV risk profiles. To compare with healthy controls, studies will be performed in populations with increased
underlying susceptibility to CV disease, such as hypertension, midlife adults, and obstructive sleep apnea. The
overall team has expertise in circadian, sleep, stress, exercise and CV physiology, and positron emission
tomographic imaging of the balance of pre- and post-synaptic adrenergic function in the left ventricle in resting
humans. The investigators will use outstanding purpose-built facilities to perform the necessary intensive, multi-
day studies with nursing, bio-nutrition and clinical support services integrated with the team’s physiological
expertise. Dr. Shea has >30 years’ experience performing clinical research mainly focused on circadian rhythms
in healthy humans and their impact on CV disease risk factors, and he has performed the majority of the CV
physiology studies in humans that use validated circadian protocols. Dr. Shea has been well-funded with 25
consecutive years as PI of investigator-initiated federal grants. Dr. Shea’s publications are well-cited with a mean
relative citation ratio of 3.84 for original research papers in the past decade [2009-18], which is higher than the
90% percentile for all NIH-funded papers in the same field [NIH Office of Portfolio Analysis: iCite Tool]). Due to
the fast emerging recognition of the magnitude and extent of circadian rhythms throughout the body, including
circadian rhythms in drug targets, we are on the cusp of meaningful chronotherapeutic trials in CV medicine that
consider internal circadian time. These preclinical studies performed in this Research Program will provide the
critical and timely background needed to fully exploit these opportunities to improve therapy of CV disease.

Public health relevance
Project Narrative There are clear day/night patterns in the timing of adverse cardiovascular events, including myocardial infarction, stroke and sudden cardiac death, which all strike most frequently in the morning. This research program will examine how circadian rhythms in the cardiovascular system, behavior-related alterations in the cardiovascular system, and an individual’s own vulnerability may interact to affect risk for adverse cardiovascular events. This research will lay the groundwork for optimizing timed therapies for cardiovascular diseases.